INTRAVENOUS IMMUNOGLOBULIN IN GENERALIZED MYASTHENIA GRAVIS

The major objective of this study is to determine if intravenous immunoglobulin is an effective therapy for myasthenia gravis. This will be established by performing a double-blind, placebo-controlled study in which MG patients will receive IVIG or albumin.